PH I STUDY OF S T &I OF MEDI 501, VIRUS LIKE PARTICLE (VLP) PAPPILOM

The purpose of the study is to learn whether or not MEDI-501, an experimental vaccine against HPV-11, is safe, tolerable, and causes an immune response in the recipient.